Advancing Foodborne Illness Prevention and Outbreak Response in the New York City Retail Food Service Environment

Project Summary/Abstract
It is estimated that there are almost 1.5 million cases of foodborne illness (FBI) in New York City
(NYC) each year, and more than 6,000 cases are serious enough to require hospitalization. Out
of the 27 FBI outbreaks in NYC that were reported to the CDC National Outbreak Reporting
Systems (NORS) in 2018, 22 (81%) were attributable to restaurants. The NYC Department of
Health and Mental Hygiene (DOHMH) is responsible for inspecting retail food service
establishments and responding to FBI outbreaks associated with them. The NYC EHS-Net
Program proposes to advance FBI prevention and outbreak response by developing data
analytic and informatics tools to improve measurement and surveillance of risk factors identified
during regulatory inspections and outbreak investigations. We will collect and use data on
environmental antecedents of FBI outbreaks to inform environmental public health practice in
NYC, and we will report data from environmental assessments to the CDC National
Environmental Assessment Reporting System (NEARS). We will also evaluate impact and
implementation of the NYC mandatory sick leave law and a restaurant letter-grading program
that was recently expanded to mobile food vendors, in addition to other policy and regulatory
approaches to reducing FBI risks. The National EHS-Net Program conducts multi-site research
studies that aim to inform public health practice in the area of retail food safety. NYC has
participated and will continue to participate fully in these studies.

Public health relevance
Project Narrative The NYC EHS-Net Program will use data and informatics tools to improve measurement and surveillance of foodborne illness risk factors in the NYC retail food service environment. We anticipate three outcomes associated with the work we propose: 1) faster and more accurate identification of risk factors, 2) interventions or policies that effectively address those risk factors and thereby reduce incidence of FBI, and 3) improved public health practice, including implementation of evidence-based food safety regulations and policy, distribution of effective educational resources to food service workers, and more efficient and effective inspectional programs.